Novel strategies to resolve metabolic defects in the diabetic heart

ABSTRACT
Diabetic cardiomyopathy is an independent risk factor for heart failure characterized by diastolic dysfunction
and left ventricular hypertrophy. Diabetic cardiomyopathy features striking changes in cardiomyocyte fuel
metabolism, which promote the transition into an advanced pathological state. Alterations in fuel metabolism
include an increased reliance on fatty acid oxidation for mechanical energy production, at the expense of other
substrates such as glucose. The resultant loss of metabolic flexibility can result in reduced cardiac work
efficiency and contractile dysfunction. The cellular mechanisms that drive changes in fuel substrate utilization
are not fully understood, and this deficiency represents a major impediment to the development of novel
treatments. In this proposal, we aim to investigate the utility of a novel peptide – adropin – to reverse the fuel
metabolism defects observed in diabetic cardiomyopathy. In Aim 1, we will investigate the effects of adropin on
novel cellular pathways that regulate glucose oxidation in the heart. In Aim 2, we will examine the role played
by adropin signaling pathways in regulating mitochondrial fuel metabolism. In Aim 3, we will examine whether
adropin is a candidate molecule for diabetic cardiomyopathy treatment in pre-clinical animal models. It is
expected that these studies will elucidate new cellular pathways that are central to the metabolic dysfunction
observed in diabetic cardiomyopathy, and will highlight potential new treatment pathways for this disorder.

Public health relevance
PROJECT NARRATIVE Diabetic cardiomyopathy is an independent risk factor for heart failure, and is characterized by striking changes in cardiac fuel metabolism. Alterations in fuel metabolism may lead to energy deficits in the heart, which can promote or exacerbate cardiac contractile dysfunction. In this proposal, we aim to investigate whether a recently discovered circulating peptide can reverse metabolic changes in the diabetic heart, and lead to improved cardiac function in pre-clinical diabetic cardiomyopathy models.